microRNA regulation of NMNAT-mediated Neuroprotection against Peripheral Neuropathy and Chronic Pain

MicroRNA Regulation of NMNAT-Mediated Neuroprotection Against Peripheral Neuropathy and
Chronic Pain
PROJECT SUMMARY
Peripheral neuropathy and neuropathy pain can be caused by a myriad of genetic and environment
factors as well as therapeutic or recreational drug use. In particular, chemotherapy-induced peripheral
neuropathy (CIPN) is the major dose-limiting neurotoxic side effect of standard chemotherapy regiments. Over
68% of cancer patients experience neuropathic symptoms after chemotherapy, and that contributes to a
significant percent of the population that suffer from chronic pain and have to resort to opioid use. Currently
there are no effective treatments available, largely due to a lack of understanding of the in vivo mechanisms of
CIPN and related peripheral neuropathy. Recently, we have optimized a model of peripheral neuropathy using
Drosophila larvae that recapitulates salient behavior and neuronal morphological aspects of chemotherapy-
induced sensory dysfunction. Our preliminary work using this model has uncovered a new mechanism
underlying peripheral neuropathy, and identified a neuroprotective protein NMNAT with promising potential for
mitigating neuropathic pain. The ultimate goal of our research is to uncover the endogenous mechanisms
underlying peripheral neuropathy and to identify neuroprotective mechanisms and potential targets that
facilitate the development of new therapeutic agents against CIPN and related neuropathic pain.
Our previous work on neuronal maintenance and protection has identified NMNAT (nicotinamide
mononucleotide adenylyl transferase), the last enzyme in NAD+ synthesis pathway, as an essential gene that
maintains neuronal structural and functional integrity. Extensive mechanistic studies from our lab and others
have found NMNAT proteins in Drosophila and mammals to be among the most robust and versatile
neuroprotective factors, and a positive correlation between NMNAT expression levels and the neuronal self-
protective capacity. Excitingly, from a compound screen, several natural compounds were identified to
upregulate NMNAT transcription, and we have collected intriguing preliminary results suggesting that the
expression of NMNAT is regulated by microRNAs. We hypothesize that regulation of NMNAT RNA expression
by natural compounds and microRNAs at the steps of transcription, pre-mRNA splicing, and mRNA stability
allows rapid and dynamic shifting between NMNAT mediated NAD+ metabolism and neuronal resilience, and
confers protection in sensory neurons against peripheral neuropathy. In this application we outline
experiments to (1) identify microRNAs that regulate nociceptive hypersensitivity, (2) identify and characterize
the molecular pharmacology of natural compounds in regulating NMNAT expression, and (3) modulate NMNAT
transcriptional regulation to enhance neuroprotection against peripheral neuropathy. Within the network of
convergent pathways responding to chemotherapy induced peripheral neuropathy, understanding the
regulation of NMNAT in both NAD+-metabolism and enhancing neuronal homeostasis will facilitate discovery of
neuroprotective strategies in peripheral neuropathy and neuropathic pain.

Public health relevance
PROJECT NARRATIVE Neuropathic pain is a serious and long-term neurotoxic side effect of chemotherapy affecting more than 68% of cancer patients, and is currently without treatment. Our studies on sensory neuronal maintenance have found NMNAT proteins to be among the most robust and versatile neuroprotective factors known and have the potential to mitigate sensory dysfunction. The proposed studies will discover ways to enhance sensory neurons' self-protection abilities by efficiently regulating NMNAT expression via microRNA and neutral compounds, thus aid in the design of therapeutic treatments for neuropathic pain.